OPEN LABEL EXTENSION OF THE DOSE RANGE AND SHORT TERM EFFICACY STUDY OF UP269-6

The purpose of this study is to evaluate the long-term tolerance and safety f UP 269-6 in comparison to enalapril, with or without the addition of hydrochlorothiazide.